Gene Regulatory Mechanisms of Mll4 in Tooth Enamel Development

Project Summary/Abstract
In the U.S., more than 10% of infants are born with dental anomalies, including amelogenesis imperfecta (AI), a
group of inherited enamel disorders caused by disruptions in gene expression. The study of enamel
development, or amelogenesis, is critical for understanding these congenital disorders and developing novel
therapies, which could have significant implications for oral health. However, the transcriptional and epigenetic
mechanisms that regulate amelogenesis remain poorly understood. Kabuki syndrome, a rare genetic disorder
caused by mutations in the MLL4 (KMT2D) gene, often presents with dental anomalies such as enamel defects,
highlighting the importance of understanding the molecular mechanisms underlying enamel development. The
long-term goal is to identify and characterize epigenetic regulators that control enamel development and
contribute to dental anomalies like AI. The objective of this proposal is to define the role of MLL4, an epigenetic
coactivator, in amelogenesis and explore why mutations in MLL4, as seen in Kabuki syndrome, lead to enamel
defects. MLL4 is a histone H3-lysine 4 methyltransferase that promotes transcriptionally active chromatin,
facilitating gene expression, but its role in regulating enamel formation is still unclear. To address this, a
conditional knockout (Mll4-cKO) mouse model was generated, enabling robust deletion of Mll4 in dental epithelial
cells responsible for amelogenesis. Based on preliminary studies, the hypothesis is that MLL4 coordinates
multiple stages of amelogenesis by regulating gene expression necessary for cell differentiation and enamel
formation. Using a combination of histological, radiographic, cellular, biochemical, genetic, and genome-wide
approaches, along with an established Mll4-cKO mouse model that exhibits AI, two key questions will be
investigated. Aim 1 will define the stages of amelogenesis that require Mll4 activity using the mouse incisor
model. Aim 2 will delineate the molecular mechanisms by which Mll4 governs gene expression at different
amelogenesis stages. Collectively, these experiments will provide crucial insights into the regulatory
mechanisms driving enamel formation and could offer novel therapeutic targets for AI and other dental disorders.

Public health relevance
Project Narrative Despite significant advancements in understanding tooth formation, the molecular mechanisms driving tooth development, particularly enamel formation, remain poorly understood. This research aims to uncover the gene regulatory programs governing enamel development and investigate why specific genetic mutations lead to congenital dental enamel anomalies. Gaining insights into these regulatory mechanisms is crucial for improving strategies to diagnose, prevent, and treat both congenital and acquired dental disorders.